Treatment of Bipolar Disorder in Old Age

DESCRIPTION (provided by applicant): This 2nd revision of an application for a competing renewal of an Independent Scientist Award seeks funding to support development of the candidate's research on the treatment of late-life bipolar disorders and his mentorship of young investigators. This research program addresses the need for evidence that can help individualize the management of these underserved patients by examining proposed clinical and neurobiological predictors of inter-individual differences in benefit from first line pharmacotherapies. Having initiated the multi-center GERI-BD study of acute treatment of manic bipolar elders, and its Coordinating Center, the candidate aims to use this platform to explore the utility of selected measures of frontostriato-limbic impairment as predictors of resistance to anti-manic treatment. Three Pilot Studies will focus on affect-laden executive tasks, neuroimaging of white matter integrity, and neurotransmitter-related genetic variation. Conducting these Pilot Studies will enable the candidate to expand his knowledge base in cognitive and affective neuroscience, neuroimaging and pharmacogenetics, and related analytic issues, through interaction with expert advisor/collaborators. This career enhancement is intended to foster development of his research to address the needs of elderly patients who do poorly with optimal standard treatments, and to study the management of other phases of bipolar illness in late life. It is also intended to support continuation and expansion of his mentorship activity. As the population ages, greater numbers of elders present with bipolar disorder. They suffer from severe symptoms, disability, and high mortality. These studies can provide findings that use relatively non- invasive and cost effective methods, derived from neuroscience and neurobiology, to develop safe and effective treatment approaches.